Role of sirtuin 6 in melanoma development and progression

Melanoma incidences are increasing rapidly with 100,350 cases predicted in 2020 in the US. Further,
melanoma is a significant problem in Veterans, and it is among the five most frequently diagnosed cancers
among VA cancer patients. Malignant melanoma is one of the deadliest forms of cancer, and the existing
therapeutics, including recently approved BRAF inhibitors, have not been fully effective in melanoma
management due to acquired resistance. Therefore, novel target-based approaches are needed for the
management of this neoplasm. We have an ongoing research program to define the role of sirtuins in
melanoma. The mammalian sirtuins constitute a family of seven members (SIRT1 – SIRT7), which play critical
roles in important cellular processes, and are involved in a variety of diseases, including cancer. The role of
SIRTs in cancer is complex, and they appear to have dichotomous functions depending on cell context. Recent
studies have implicated sirtuin 6 (SIRT6), a predominantly nuclear protein, in regulating pathways involved in
gene transcription, glucose homeostasis, DNA repair and telomere integrity. SIRT6 has been found to
suppress tumorigenesis in the intestine and liver. However, SIRT6 also has a pro-proliferative role in skin and
prostate cancer, suggesting that its function may be tissue- and context- dependent. Interestingly, SIRT6 has
also been shown to modulate epithelial-mesenchymal transition (EMT) and promote metastasis in certain
cancer types. In a recent study, we have demonstrated that SIRT6 is overexpressed in human melanoma cells
and tissues, and SIRT6 inhibition via shRNA-mediated RNA interference resulted in a marked antiproliferative
response (growth inhibition, cell cycle alternation, inhibition of cell migration, senescence and autophagy
dysregulation) in melanoma cells. Our preliminary data and published study together with other published
research provide a strong scientific premise to our investigation into the role and potential therapeutic
significance of SIRT6 in melanoma and supports our proposed hypothesis that SIRT6 plays a critical role in
melanocytic transformation and melanoma progression and together with other driver pathways, can be
therapeutically exploited for melanoma management. The following specific aims are proposed: 1) To define
the role of SIRT6 in melanoma development and progression and its association with critical melanoma driver
pathways employing a tissue microarray (TMA) created from retrospective melanoma tissues from Veteran
patients. In this aim, we will determine the role of SIRT6 in melanoma as well as its association with critical
melanoma driver pathways (RAS/RAF/MEK/ERK-, and p16/cyclin D-CDK4/6-RB- pathways); 2) To determine
the functional and mechanistic significance of SIRT6 in melanoma. In this aim, we will determine the effect of
CRISPR/Cas9 mediated SIRT6 deletion on growth and progression of melanoma cells in vitro and in vivo; and
3) To determine the therapeutic significance of SIRT6 inhibition alone and in combination with other promising
target-based anti-melanoma modalities in vivo. We will determine the effects of SIRT6 inhibition using small
molecule SIRT6 inhibitor alone and in combination with other clinically relevant melanoma therapies (BRAF
inhibitor, Vemurafenib; and MEK inhibitor, Trametinib) on melanoma development, growth and metastasis in 1)
Braf-Pten mouse model, and 2) patient-derived xenografts (PDX). We expect that our study will define the role,
mechanism, and interactions of SIRT6 in melanoma as well as novel combinations in pre-clinical settings,
which could be useful for future clinical investigations. This may ultimately lead to the development of novel
diagnostic, prognostic, and therapeutic approaches for melanoma. Hence, our proposed study is relevant and
significant to the health care of Veterans and is in line with the mission of the Department of Veteran Affairs.

Public health relevance
Melanoma is one of the five most frequently diagnosed cancers in VA patients. Veterans appear to be at higher risk of melanoma due to deployment to tropical/subtropical zones with high ultraviolet (UV)-index climates and exposure to certain chemicals. Despite recent advances in the treatment of melanoma, existing therapies are not able to fully manage melanoma incidences or fatalities. Therefore, new molecular targets and treatments will be required to effectively manage this cancer. The goal of this study is to define the role and mechanism of the protein SIRT6 in melanoma. SIRT6 plays complex roles in several other types of cancer, but its function in melanoma has not been fully established. We will investigate the role of SIRT6 and the therapeutic significance of inhibiting SIRT6 – alone and in combination with existing melanoma therapies – in several clinically-relevant models. The outcomes of our proposed study may lead to the development of novel diagnostic, prognostic and therapeutic approaches that will improve the management of melanoma in Veterans.